AR gene rearrangements and AR signaling in prostate cancer

PROJECT SUMMARY/ABSTRACT
Prostate cancer (PC) is the most frequently diagnosed male cancer and second leading cause of male cancer
death. Inhibiting activity of the androgen receptor (AR) is the primary treatment modality for relapsed or
metastatic PC. Invariably, PC recurs with a lethal castration-resistant (CR) phenotype that is resistant to AR-
targeted therapies. Clinical and experimental evidence supports the current paradigm that AR reactivation is a
key driver of this resistance, supporting continued growth and progression of CRPC. This knowledge has led
to the development of new therapies that inhibit AR reactivation in CRPC, but resistance remains a persistent
problem for patients. The long-term objectives of this research are to determine the mechanisms that can
support persistent AR transcriptional activity despite AR-targeted therapy, and to develop new strategies for
treating patients with CRPC. The central discovery driving this project is a high frequency of structural
rearrangements affecting the architecture of the AR gene, specifically in tumors obtained from CRPC-stage
patients. The major challenge is the diversity and heterogeneity of these AR gene rearrangements, on both an
intra-patient and an inter-patient basis, which poses a barrier to developing a mechanistic understanding of
their clinical significance and therapeutic targeting. Preliminary data presented in the proposal show that
diverse AR gene rearrangements impart a growth advantage for CRPC cells grown under the selective
pressure of AR-targeted therapies, indicating that they play a central, albeit poorly-understood, role in
resistance. Preliminary data also show that a common molecular outcome of these AR gene rearrangements
is synthesis of truncated AR variants lacking the AR ligand binding domain. These AR variant species are able
to support persistent AR transcriptional activity through mechanisms that are constitutive, ligand independent,
and antiandrogen resistant. The overarching goals of this project are to understand the generality with which
this new resistance mechanism occurs in CRPC-stage tumors and identify new therapeutic targets. To
achieve these goals, we will develop new genomics technologies that will enable accurate identification and
reconstruction of the rearranged AR gene architectures occurring in the tumors of CRPC patients. We will also
use genome engineering approaches to understand whether diverse AR gene rearrangements are functionally
equivalent in driving resistance to AR-targeted therapy, and understanding the necessity and sufficiency of AR
variants for promoting this phenotype. Finally, the molecular mechanisms by which AR variants bind chromatin
and achieve constitutive transcriptional activity will be elucidated, with emphasis on co-regulators that support
these activities. These co-regulators will be evaluated as targets for inhibiting activity of AR variants
downstream of AR gene rearrangements. Overall, success with these studies will elucidate the role of a
frequent yet unexplored class of alteration impacting the AR gene in CRPC-stage tumors and identify new
molecular targets for inhibiting AR reactivation in CRPC.

Public health relevance
PROJECT NARRATIVE The majority of prostate cancer mortality is due to failure of hormonal therapies to maintain a durable suppression of androgen receptor activity. The proposed studies are focused on understanding how androgen receptor activity can persist in prostate cancer cells during hormonal therapy. This knowledge is expected to reveal new opportunities for suppressing androgen receptor activity therapeutically, which could improve survival of prostate cancer patients.